Designed Multiple Ligands as Non-opioid Analgesics for Treating Chronic Pain

Project Summary/Abstract
Chronic pain is the primary cause of disability worldwide. According to the National Institutes of Health, nearly
25.3 million Americans suffer from daily pain, and another 23.4 million Americans report significant pain.
Approximately 1 in 5 adults worldwide suffer from pain, and another 1 in 10 adults are diagnosed with chronic
pain each year. We aim to develop dual inhibitors, single small molecules that will simultaneously inhibit two
enzymes: soluble epoxide hydrolase (sEH) and fatty acid amide hydrolase (FAAH). The most original and
mechanistically distinct aspect of these compounds is their ability to simultaneously inhibit two different enzymes
that play significant roles in pain and inflammation. Dual sEH/FAAH inhibitors described here have the potential
to be used as a promising novel non-opioid therapeutic strategy in pain management. In our previous NIH SC2
grant (GM135020), we identified several very potent dual inhibitors, and one was tested in a rat model of acute
inflammatory pain. Demonstrating antinociception of this dual inhibitor provided the first evidence that a dual
sEH/FAAH inhibitor alleviates acute inflammatory pain induced by intraplantar injection of dilute formalin. We
also observed that this dual inhibitor produces antinociception at lower doses than the traditional nonsteroidal
anti-inflammatory drug ketoprofen. In the proposed studies, we will synthesize and evaluate novel libraries of
ligands that are designed to interact simultaneously with both target enzymes, assess and improve the drug-like
properties of these molecules, and evaluate whether two previously identified dual inhibitors together with the
new compounds (identified in this proposal) produce pain relief against chronic inflammatory pain in vivo in a rat
model of chronic inflammatory pain.
The compounds we propose to study represent a much-needed, completely novel non-opioid starting point in
pain management research. Because this class has different biological targets from existing analgesics, it
represents an opportunity to solve long-standing problems that have been linked to the existing opioid and non-
opioid therapies in pain management. To our knowledge, this proposal is the first attempt to use the strategy of
dual sEH/FAAH inhibitors as a rational therapeutic strategy for pain management. In addition, the design
principles and synthetic and in vivo tools behind these dual inhibitors are rigorous, comprehensive, and
innovative. This multipronged plan is a forte in our dual inhibition generation/optimization program. Our studies
may provide a foundation for the future investigation of the benefits of using the dual ligand strategy in analgesia.
This proposal represents a collaborative work between two Hispanic-serving institutions, California State
University, Fullerton and California State University, East Bay, with a strong collaborative partnership with the
University of California, Davis. Our multidisciplinary team has the expertise and resources to tackle this project
on the horizon to ensure continued success.

Public health relevance
Project Narrative There has been little innovation in the development of the new analgesic drugs that target novel mechanisms of action. We will focus on the structure-activity relationship studies, biological evaluation, behavioral testing, and optimization of the new dual inhibitors of soluble epoxide hydrolase and fatty acid amide hydrolase enzymes, to increase the levels of anti-inflammatory and analgesic metabolites in the body. Through in vitro and in vivo studies, we aim to demonstrate that the designed dual inhibitors are effectively inhibiting both aforementioned enzymes simultaneously, are metabolically stable, and can produce pain relief in a rat model of chronic inflammatory pain with the potential to become novel, safe, and effective non-opioid treatments for patients suffering from chronic pain.